Heading and Soccer: Understanding Cognitive Risks, Benefits, and the Potential Mediating Role of White Matter

PROJECT SUMMARY/ABSTRACT
A key goal of “Healthy People 2030” is to improve the health of adults through aerobic physical activity. Soccer,
the most popular sport on earth, is an aerobic outlet for more than 25 million Americans. The potential benefits
of soccer are offset by repetitive subconcussive head impacts (RSHI) from soccer heading. RSHI are associated
with exposure-dependent adverse effects on neuroimaging and on cognitive performance, independent of
collisions and concussion. The tradeoffs between aerobic benefits and RSHI-related harms are not known. The
central aim of this proposal is to examine the aerobic benefits of soccer play, in relation to RSHI harms,
for brain structure and function, and to explore person-level factors that modify this risk-benefit tradeoff.
Beneficial effects of aerobic capacity and adverse subclinical effects of RSHI can be detected with neuroimaging
of white matter. However, little is known about their joint impact on white matter and, in turn, how white matter
features mediate effects on cognitive function. Fundamental knowledge on the RSHI risk-benefit balance can
inform our understanding of RSHI morbidity and its mitigation beyond the specific context of soccer, such as
other sports and combat. Prior work on RSHI effects has not specifically measured aerobic capacity, and little is
known about whether and how white matter mediates exposure-outcome associations. Our proposed 2-year
longitudinal follow up study of 280 young adults, including soccer players with high (n=70) and low (n=70)
exposure to RSHI, non-collision athletes (n=70) and non-athlete controls (n=70), will test the hypothesis that
aerobic capacity-engendered benefits confound and modify the adverse effects of RSHI on white matter
that, in turn, is a mediator of adverse cognitive effects. We will measure aerobic capacity (VO2max) and
RSHI over 2 years and perform Myelin Water and Microstructure MRI of white matter as well as cognitive
assessments, at enrollment and 2 years later. We will address the following specific aims: Aim 1: Evaluate the
joint effects of VO2max and RSHI on white matter myelination and microstructure. Aim 2: Assess mediation by
white matter of the known associations of VO2max and RSHI with cognitive performance. Aim 3: Explore the
BDNF-Val66met and ApoE-ε4 gene variants as modifiers of the tradeoff of VO2max and RHSI-mediated effects
on white matter. Delineating risk vs. benefit to cognitive performance from soccer can transform perception of
risk by stakeholders, facilitate choice and guidance on soccer participation and heading. Choices that impact
young adult players, with high RSHI exposure and decades of future needs, have the potential to impact their
wellbeing, healthcare footprint and productivity for decades.

Public health relevance
PROJECT NARRATIVE – PUBLIC HEALTH RELEVANCE A key goal of “Healthy People 2030” is to improve health of adults through aerobic physical activity, and soccer, which is the most popular sport on earth, is an aerobic outlet for more than 25 million Americans of all ages that provides significant benefits for brain health. However, we and others have shown that repetitive subconcussive head impacts from soccer heading are associated with signs of subclinical brain injury among young adults, which impact function and may pose risk for neurodegeneration. Delineating the risk vs. benefit to cognitive performance from soccer, based upon a robust scientific foundation, can transform perception of risk by stakeholders and facilitate guidanceon soccer participation for young adult players with decades of future needs, and potential to impact their wellbeing, healthcare footprint and productivity for decades.